CRCNS: Switching antennal lobe dynamic regime via olfactory and mechanical signal

PROJECT SUMMARY (See instructions):
Multimodal integration is a fundamental feature of animal nervous systems that allows them to extract
useful information from complex environmental signals and guide behavior. A defect in this process may
lead to communication disorders. However, there is currently limited understanding of this pervasive
phenomenon. Due to its simplicity, the honeybee antennal lobe (AL) provides an excellent system for
studying sensory integration. Chemical (i.e., odor) and mechanical (i.e., wind speed) information converge
within the AL, likely in service of two intermingled tasks facing honeybees - tracking highly turbulent odor
plumes and discriminating odors. Both are critical for foraging success. This proposal seeks to: (1)
determine the impact of mechanical input (wind speed) on AL odor responses and odor classification; (2)
determine the functional roles and mechanisms of multisensory integration within the AL. We postulate that
the AL can switch between two distinct dynamic regimes – an odor tracking regime (triggered by high
mechanical input) and an odor discrimination regime (triggered by low mechanical input). In other words,
input from one modality affects the coding scheme of the other. To test this hypothesis, our experimental
work will entail a suite of electrophysiological experiments that disentangle the contributions of each
modality to AL dynamics, determine the impact of mechanical input on correlations across the AL, and
assess the dependence of AL odor classification on mechanical input. Computationally, we will construct a
realistic, experimentally benchmarked spiking network model of the AL integrating mechanical and olfactory
inputs, and use it to study the network mechanisms that underlie AL dynamics within the two postulated
regimes. The model will be used to explore conceptual ideas and generate specific hypotheses that will be
tested in subsequent experiments. Finally, we will incorporate the fundamental principles uncovered in our
work into novel machine learning algorithms for solving multimodal problems. The PIs are excellently suited
for the proposed work – Dr. Lei is an expert in olfaction and the electrophysiological studies of the AL, Dr.
Patel has extensive experience in biologically realistic modeling of AL dynamics, and Dr. Bazhenov is an
expert in computational neuroscience, data analysis and machine learning.

Public health relevance
RELEVANCE (See instructions): Integration of different sensory modalities is a common cognitive capability and a foundation of communication processes. Inability to properly process simultaneous channels of sensory inputs may lead to symptoms expressed by patients of autism disorder spectrum (ASD). Better understanding of the mechanisms and brain dynamics underlying multisensory integration will facilitate understanding communication processes in healthy subjects as well as the underpinnings of communication disorders.